Disruption of epigenetic regulation of enhancers in the germinal center reaction drives clonal evolution in Follicular Lymphoma

PROJECT SUMMARY/ABSTRACT
Follicular Lymphoma (FL) is the second most common form of non-Hodgkin's lymphoma, accounting for 20-
30% of non-Hodgkin's lymphoma diagnoses. Though FL is an indolent disease, it eventually transforms into
more aggressive, incurable forms of lymphoma. FL is hallmarked by the anti-apoptotic IGH/BCL2 translocation,
which is often accompanied by a mutation in an epigenetic gene. Here, we propose to investigate the roles of
these mutations in epigenetic genes, specifically KMT2D and CREBBP due to their high rate of occurrence, in
the development and transformation process of FL. In our first aim, we plan to use mixed bone marrow chimera
mouse models to determine the role of these mutations in driving early clonal evolution of the disease. In our
second aim, we plan to then characterize the gene expression and chromatin accessibility of the resulting
lymphoma to determine how these mutations cooperate to drive progression through epigenetic reprogramming
of the tumor.

Public health relevance
NARRATIVE Follicular lymphoma (FL) is an indolent disease, displaying few symptoms, and standard clinical practice is to monitor the patient without treatment. However, over time it transforms into more malignant, incurable diseases such as DLBCL. To better inform treatment timing, this study proposes to use mouse models of lymphoma and single cell assays to determine the role of mutations in epigenetic genes often found in FL in both early clonal evolution and the later transformation process.